All of Us Coast-to-Coast Strong recrUitment, Retention, and Facilitation (C2C SURF)

The Coast-to-Coast Consortium (C2C) proposes Strong Recruitment, Retention, and Facilitation through innovation (SURF). C2C combines experienced sites to provide innovative and committed support to NIH goals for (1) strong biomedical research enrollment, retention, and facilitation; (2) use of implementation and data science best practices; and (3) increase return of value to participants. Our use of implementation science will improve data-driven decision making, and establish the right balance between costs per participant and successful recruitment and retention of participants. Our institutions will recruit new participants in All of Us partnership research projects, continue passive retention strategies, as well as support current participants. This will be accomplished through existing and new outreach efforts and partnerships that take advantage of our extensive catchment areas. Of the institutions involved, two are recruiting for the AoU Nutrition for Precision Health study, and two for the Ocular Imaging study. Our multidisciplinary team has a strong track record of collaborative research, which facilitates working together successfully. Our multi-PI team has a combination of leaders in their fields.

Public health relevance
The All of Us Research Program is building a cohort of over a million individuals who consent for the use of their data and biospecimens for health-related research. The Coast-to-Coast (C2C) Consortium is composed of a set of healthcare provide organizations that help All of Us recruit, retain, and facilitate interactions with the populations cared by their health systems.